Integrated movement tracking for pediatric OPM-MEG studies of intellectual disability

Abstract
This R61/R33 project will develop an advanced technology for non-invasive recording of whole-brain physiology
with synchronized video-tracking of movement for use in children with intellectual disability and will use it to
elucidate the brain-circuit electrophysiology of intellectual development. The technological advances will have
immediate benefits for pediatric neurology and will be widely applicable to many neurological disorders in which
safe and convenient, non-invasive recordings of brain physiology are desired to inform diagnosis, prognosis, and
treatment. The R61 phase will be performed by FieldLine Medical (Boulder, CO) which will contribute their recent
advances in optically-pumped magnetometer magnetoencephalography (OPM-MEG), a transformative
technology for safe, physiological brain imaging that greatly increases sensitivity to brain electrical signals as
compared to SQUID-MEG and EEG and provides greater coverage than invasive electrophysiology. FieldLine
will: 1) expand the capabilities of their HEDscan OPM-MEG system, as a “wearable” brainwave scanning
technology, for high-fidelity MEG recordings in freely moving children; and 2) integrate synchronized video-
tracking of voluntary movements for kinematic analysis to create a technology named HEDscanV. The R33
phase will deploy HEDscanV in two pediatric neuroscience laboratories at the Children's Hospital of Philadelphia
and Seattle Children's Research Institute. After validating HEDscanV in children against SQUID-MEG, the R33
phase will leverage advances in autism research enabled by sensory, motor, and associative learning paradigms
that were developed by the MPIs to identify intellectual disability with high accuracy. By disseminating HEDscanV
and sensory-motor paradigms across clinical sites in Philadelphia and Seattle, we will work together to identify
the bandwidths of electrical activity coherence in brain circuits at the interface of movement and cognition that
promote intellectual development. Our success will be ensured by the support of two nationally-recognized
autism centers at the University of Washington and Children's Hospital of Philadelphia, where high-fidelity clinical
assessments and diagnostic testing will be conducted. By establishing the locations and bandwidths of activity
coherence in the brains of children that promote intellectual development, the project will begin to lay the
essential groundwork needed to establish therapies intending to normalize brain pathophysiology and facilitate
intellectual development in children with neurodevelopmental disorders.

Public health relevance
Narrative This project will develop “wearable” magnetoencephalography with synchronized movement video tracking for use in freely-moving children that will be used to elucidate the brain circuit activity which promotes intellectual development. The participants will be school-age children with typical development and with varying degrees of intellectual disability related to autism spectrum disorder. By defining the frequency bandwidths and brain locations of electrical activity coherence that promote intellectual development, the project will lay the essential groundwork for future therapies that will remediate intellectual disability in children.